BIOLOGY OF CUTANEOUS MALIGNANT MELANOMA

Our research covers six different areas related to the cellular evolution characteristic of primary melanomas and to the formal histogenetic precursors of malignant melanoma. These six areas of investigation are: (1)\natural language access to the computerized database of all of the melanomas studied prospectively by the Pigmented Lesion Study Group of the University of Pennsylvania; (2)\studies of dysplastic nevi, the important histogenetic precursors of melanoma, in familial and sporadic melanoma; (3)\fine-structural studies of primary melanomas, dysplastic nevi, normal nevi, and Spitz tumors; (4)\studies of the phenotypic characterizations of cells cultured from normal nevi, dysplastic nevi, and melanomas; (5)\a variety of studies with antimelanoma monoclonal antibodies emphasizing their use with immunoperoxidase methods to detect melanoma-associated antigens in intact human tumors; and (6) studies of lymphocyte subsets in the host response to melanocytic neoplasms. (W)